Statistical Approaches to Unlock Protein Function from Deep Mutational Scans

Project Summary/Abstract
Understanding how genetic variants impact protein function is essential for unraveling the mechanisms
underlying both basic biology and disease, particularly for rare genetic variants. Of the 4.6 million missense
variants found in large population studies, only about 2% have clinical interpretations. Due to their rarity, these
variants are exceptionally challenging to study through observational methods. However, Deep Mutational
Scanning (DMS) offers a high-throughput method for testing thousands of protein variants by generating a
mutant library and obtaining a phenotypic readout for each mutation in one sequencing assay. Initially focused
on fitness-based readouts, DMS has expanded to include fluorescence-based methods for protein profiling,
binding assays, and more. It has been crucial for studying proteins like SARS-CoV-2, BRCA1, and
drug-metabolism transporters like OCT1. With over 1,000 protein datasets publicly available, a recent study
highlights technical advances by independently assaying over 500 additional proteins in one study.
Unfortunately, the development of statistical methods to interpret and analyze these technologies has
not kept pace. For example, DMS with fluorescence-activated cell sorting (DMS-FACS), which has been used
for nearly a decade to measure protein abundance and other functional phenotypes, still lacks dedicated
analysis methods. As a result, analyses are often ad hoc, and small sample sizes (typically three replicates)
make standard statistical methods unsuitable. Our recent work demonstrates that naive approaches miss
many real effects and lead to many false discoveries. We propose three statistical areas to improve DMS
analysis and interpretation through accurate sample comparisons, epistasis analysis, and causal inference.
First, we will develop methods to analyze DMS-FACS for assessing how genetic variants affect
molecular phenotype targeted by FACS, and enabling precise comparisons between experimental conditions.
Second, we will develop methods to improve genetic interaction (epistasis) analysis and interpretation within
proteins, and thus ask which protein regions are acting in concert. Third, we open a new area of research for
DMS, aiming to identify the causal impact of variants through measured pathways, including complex traits.
In summary, we will solve the analysis gap for DMS-FACS, epistasis DMS, and causally link DMS data
through structural causal models by leveraging our expertise in DMS data and small sample statistics.
Leveraging our expertise in DMS data and small sample statistics, we will create reliable, robust tools for
common workflows while also enabling new types of analyses that improve the interpretation of DMS,
epistasis, and phenotypic relationships. With strong collaborations with assay developers and DMS experts,
along with a proven track record in developing tools for high-throughput sequencing in small sample contexts,
we are well-positioned to lead this effort.

Public health relevance
Project Narrative Although we have discovered millions of rare genetic variants in large population studies, we have only characterized about 2% of them. A technology, Deep Mutational Scanning (DMS), enables us to study many of these rare protein variants experimentally, but is currently lacking rigorous statistical tooling to robustly analyze and interpret these data. This proposal develops statistical models for the analysis and interpretation of various types of DMS data to enable studying many molecular phenotypes, genetic interactions, and their connections at both the molecular level and disease level.